SOMNAR: A platform to localize airway obstruction in sleep apnea

Abstract -
An estimated 24 million undiagnosed or untreated people with OSA (obstructive sleep apnea) contribute to a
$150B economic burden in the US. Most people with OSA are prescribed continuous positive airway pressure
(CPAP) as a first line treatment, but CPAP has a 50% failure rate. Highly effective treatments that target the
anatomic causes of OSA are available but are only effective when the anatomical source of apnea is
appropriately identified. Currently there is no accessible diagnostic that can query airway anatomy during natural
sleep. Increasingly, sleep surgeons use Drug-Induced Sleep Endoscopy (DISE) to investigate the upper airway
anatomy for OSA surgical planning. This diagnostic is subjective, a drain on surgeon time and operating room
resources, inconvenient for patients, and cannot be performed during natural sleep. Several methods have been
investigated to identify obstruction sites during natural sleep, such as using MRI to image the airway of sleeping
patients or introducing a thin tube with multiple pressure sensors into the upper airway. However, these methods
are cost prohibitive, impractical for clinical use, or not tolerated by every patient. Bairitone Health proposes to
develop a platform for the anatomic diagnosis of obstructive sleep apnea (OSA). The technology detects
tissue-borne sounds, recognizes their association with normal breathing or airway obstruction, and
identifies the location in the upper airway they emanate from. The overall goal of this Phase I project is to
demonstrate that Bairitone Health’s approach for localization of airway obstructions is technically feasible and
can be developed into a clinical application. To accomplish this goal, Bairitone Health has four specific aims: 1)
develop and train an algorithm to recognize post-apnea snore events indicative of airway reopening, 2) develop
speech-based calibration and airway-obstruction localization methods, 3) optimize the localization method on a
3D-printed human head model by generating sounds at specific locations within the model's airway, and 4)
develop an updated prototype of the sound recording device and sensor configuration. If successful, the platform
will allow the diagnosis of OSA and determination of its anatomical source in one single procedure, streamlining
the process and cutting costs. Completing these aims will validate the technical feasibility of the platform and
usher the technology towards commercial application. Moving the anatomy assessment from the operating room
to the home will result in higher OSA diagnostic capacity. In the future, Bairitone Health plans to integrate
traditional diagnostics collected in current home sleep tests into the home-based anatomy assessment. With the
anatomy information the diagnostic platform can provide, this product will become the first-choice testing tool for
obstructive sleep apnea diagnosis and personalized treatment planning.

Public health relevance
Narrative – Despite having access to multiple treatments and diagnostic tools for OSA (obstructive sleep apnea), clinicians lack access to an easy-to-use home device able to provide non-invasive information on the anatomical location of airway obstruction during natural sleep, which would expand diagnostic capabilities and facilitate effective treatment of the disease. Bairitone Health’s device will be used at home, and lead to better patient outcomes by increasing the number of patients a) diagnosed with OSA, and b) evaluated for airway obstruction location, so that they are matched with the best possible treatment option for their individual anatomical features. This innovation would benefit the estimated 24 million undiagnosed or untreated people with OSA in the United States.